Surgical Oncology Research Training Grant

PROJECT SUMMARY/ABSTRACT
We propose to continue our program to provide research training in oncology to young surgeons interested in a
career in academic surgical oncology. Trainees will be surgical residents with at least 2 years of postgraduate
clinical experience. Our T32 Surgical Oncology Research Training Program has supported the research
careers of 85 young trainee surgeons over the past 30 years. We are now applying for funding for years 31 to
35. The goals of the 2-year training program are to provide individuals with an intensive research experience in
(1) hypothesis formulation, (2) experimental design, (3) data analysis, (4) laboratory/project management, (5)
oral and written presentation, and (6) grant writing skills. The ultimate objective of the program is to teach the
scientific method and research techniques so that the trainees can perform high-quality independent research
on topics ranging the full spectrum of oncology upon completion of their surgical training. This research
experience will enable trainees to apply for positions as junior faculty members in academic institutions and
become independent clinical and translational researchers. The mentored research will be tailored to the
interest and career goals of the trainees and their mentors. Past trainees have worked in a wide variety of
disciplines, including tumor immunology, cancer biology, molecular genetics, molecular pathology, and
targeted therapeutics. For the proposed cycle, we have added Program Faculty with research programs in
cancer outcomes, survivorship, and disparities. The program curriculum is now designed to provide exposure
to basic, translational, and population health sciences, as well as clinical surgical oncology, medical oncology,
and radiation oncology. Close contact between the trainees, mentors, and program director has been
achieved. Trainees are required to attend weekly conferences and didactic lectures at Memorial Sloan
Kettering Cancer Center (MSK) that include the fundamentals of research, research presentations, as well as
topics in clinical oncology. The scientific quality of research performed by the trainees has been outstanding
and most of the fellows have remained in academia. The program continues to be a major commitment of the
Department of Surgery at MSK and has benefited from the recent increase in research faculty and research
facilities at our institution.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) The T32 Surgical Oncology Research Training Program at Memorial Sloan Kettering Cancer Center has supported the research careers of 85 young trainee surgeons over the past 30 years. The ultimate objective of the program is to teach the scientific method and research techniques so that the trainees can perform high- quality independent research in oncology upon completion of their surgical training.